The 3rd annual Symposium on Hidradenitis Suppurativa Advances (SHSA) meeting

Abstract Hidradenitis suppurativa (HS) is a common inflammatory condition with a drastic negative effect on patients, but it is frequently misdiagnosed and inadequately treated. The Symposium on Hidradenitis Suppurativa Advances (SHSA) supports the missions of the HS Foundations of the United States and Canada to cure HS and improve the lives of those affected by providing a forum for: (1) Provide education and mentorship to new and established HS researchers; (2) Advance existing and new research projects focused gaps and controversies in the HS literature; and (3) Support exchange among all stakeholders to improve research and outreach. Held in October 2018, the SHSA is unique for its inclusion of researchers from across multiple disciplines, its level of patient engagement with researchers, and the ability for meeting outcomes to immediately impact the activities of two large patient advocacy organizations. The SHSA will bring together more than one hundred and fifty early and established researchers and patients for several didactic sessions on cutting-edge research, multiple poster sessions open to all attendees including patients, and discussion sessions focused on advancing HS research. This meeting aims to foster networking and collaboration between researchers and with the crucial input of people with HS in order to advance basic and translational research on HS. Proceedings of the SHSA will be disseminated to both patient and professional audiences via digital and print versions of organizational newsletters, social media, and peer-reviewed publications. The proceedings and attendee feedback will also be immediately incorporated into subsequent SHSA and HS Foundation programs and activities.

Public health relevance
Public Relevance Statement/Project Narrative This R13 conference proposal requests support for the Symposium on Hidradenitis Suppurativa Advances to be held in Toronto, October 12-14, 2018. This meeting will bring together over 150 researchers, members of industry, and people with hidradenitis suppurativa (HS) who are all interested in advancing basic and translational research for HS. Through didactic sessions by international experts, collaborative workshops, and networking session, the SHSA seeks to engage researchers and stakeholders to share knowledge and stimulate research.